ANALYSIS OF VACCINES FOR THE PRESENCE OF ADVENTITIOUS VIRAL AGENTS

Vaccines are among the most cost-effective public health measures available today. Because many vaccines are administered to all healthy children, and development of herd immunity is an important contributor to their effectiveness, it is important for the public to have confidence that vaccines are safe. It is thus very important from a public health perspective to ensure that administered vaccines are free of known adventitious agents. The goal of this project is to develop new tests that may be reliably used to test vaccines for potential adventitious agents. Most current vaccine testing relies on highly sensitive tissue culture assays. Newer molecular techniques have not in general been adapted for this kind of testing, in part because of the high reliability and sensitivity of the tissue culture assays. However, these molecular techniques have the potential to detect agents that theoretically could yield negative tissue culture results. Thus, new molecular techniques are being used to develop assays that could detect potential viral adventitious agents. Initial studies focused on the identification of SV40 in oral polio vaccine (OPV). Using sensitive PCR techniques, no evidence for continued contamination of OPV was found. Additional PCR assays to detect other simian agents in vaccines produced in monkey cells are being developed. Future studies will focus on the development of non-specific assays, that detect adventitious viral nucleic acid based on specific features of contaminating viruses, without a clear need to know the DNA or RNA sequence o f the virus being detected.